Fractionation of RBCs via label-free magnetophoresis using novel additive-manufactured devices

SUMMARY
Blood cell fractionation using magnetic fields is a promising technology capable of achieving the separation and
analysis of blood cells simultaneously, which is essential in clinical diagnosis and can provide insight into
important cellular processes that might not be able to be observed easily with other techniques. For example,
our previous studies on the analysis of red blood cells (RBCs) using single-cell magnetometry have reported that
specific fractions of cells have a low magnetic susceptibility and hemoglobin (Hb) concentration, which is related
to the maturity of the cells in circulation as well as a predictor of ex vivo cell aging. Label-free magnetophoresis
has also been able to determine that, during the approved 6-week storage period of RBC units in blood banks,
the cells lose a significant amount of magnetic susceptibility and iron concentration. Thus, label-free magnetic
fractionation can be exploited to separate the healthy, Hb-enriched cells from the damaged and iron-deficient
cells in RBC units, in order to extend their shelf life, and to ensure a better utilization of the limited resources we
currently have. Also, magnetic fractionation could be used to design novel transfusion therapies that can alleviate
the negative effects that patients requiring repeated RBC exchange transfusions suffer, since this technique can
be employed to discard detrimental RBCs with low/abnormal Hb from the patient and to recycle the healthy,
endogenous RBCs back to the individual. However, devices able to perform the specific separation of large
volumes of RBCs into different subsets with homogenous Hb in a short period of time, at a low cost, with high
purity, are not available yet. Current devices need to increase the magnetic fields and field gradient distributions
in order to perform such separation. In this regard, magnetic responsive materials that can be printed using novel
additive manufacturing techniques are a promising option to develop fractionators that can precisely isolate RBC
subsets with equal Hb concentration each. We have demonstrated for the first time the excellent magnetic
properties that magnetic responsive polymers have for cell fractionation. In this project, we will use a hybrid
additive manufacturing approach to fabricate magnetic fractionators with custom magnetic field distributions
based on novel magnetic inks and biocompatible microfluidic channels for a high-throughput RBC isolation into
4 subsets based on their Hb concentration. More specifically, our novel approach combines a stereolithography
module for microchannel printing and a direct ink writing module for the fabrication of the magnetic field sources
by varying the composition of the inks while printing. Various characterization techniques will be employed to
assess the quality of the system before we use it for human RBC fractionation. Finally, this work will also
strengthen our infrastructure to support undergraduate and graduate researchers and the enhancement of our
biomedical engineering research environment at Texas Tech University.
1

Public health relevance
NARRATIVE The fractionation of red blood cells (RBCs) based on their hemoglobin content via label-free magnetophoresis represents an attractive technology with multiple applications within blood banking and transfusion medicine. Devices that can provide the specific separation of the cells at a high throughput, at a low cost, and with high purity are needed. In this project, we will fabricate magnetic microdevices via hybrid additive manufacturing, combining stereolithography and direct ink writing technologies, and will characterize and evaluate the potential application of the devices for a fast, inexpensive, and accurate RBC fractionation based on the cell’s magnetic susceptibility and hemoglobin/iron content. 1